CUREGN 3.0 - Pediatric Nephrology Consortium - PCC

Abstract
Primary glomerular diseases, including minimal change disease (MCD), focal segmental glomerulosclerosis
(FSGS), immunoglobulin A nephropathy (IgAN), and membranous nephropathy (MN), are associated with
significant morbidity and mortality in both adults and children. Cure Glomerulonephropathy (CureGN) is a
prospective, longitudinal observational cohort study launched in 2013 to address critical knowledge gaps in the
pathogenesis, natural history, and response to therapy of these heterogeneous disorders. It is a study of
unprecedented size and remarkable depth, built by a unique collaborative interdisciplinary community. The
international consortium includes researchers with diverse expertise, affected patients and advocacy groups,
the biopharmaceutical industry, and federal funding agencies. CureGN has successfully recruited a diverse
cohort of nearly 2800 adult and pediatric participants with MCD, FSGS, IgAN and MN from more than 60
clinical study sites. Biospecimens, clinical data, and patient reported outcomes are collected to enable high-
quality clinical, mechanistic, and translational investigations. This foundational work is being conducted by a
collaborative infrastructure including the Data Coordinating Center (at the University of Michigan, Northwestern
University and Cleveland Clinic) and four Participating Clinical Centers (managed at the University of
Pennsylvania, Columbia University, University of North Carolina, and the Pediatric Nephrology Research
Consortium). CureGN is paving the way for personalized care in glomerular disease by disentangling the
heterogeneity within these disorders that are etiologically diverse but currently grouped into only four
diagnoses.
In CureGN’s third study phase, we propose to maintain and enhance the CureGN Consortium infrastructure
and ancillary studies program to accelerate patient-relevant glomerular disease research. We will continue our
core observational study, enrolling additional participants in a recruit-to-replace strategy to maintain an active
cohort of 2000 participants with high quality clinical data and biospecimens. We will implement state of the art
tools for remote data and biospecimen collection, expand biospecimen types, and implement the use of new
mobile applications for patient engagement and medical record linkages. Mature scientific working groups,
committees and ancillary infrastructure will continue to support a multidisciplinary core and ancillary study
program to achieve the scientific goals of CureGN. We will continue our outreach to the scientific community by
enhancing CureGN’s role as an outstanding training vehicle for the next generation of glomerular disease
researchers and attracting cutting-edge, established scientists to glomerular disease through opportunity pool
grants, collaborations with patient advocacy groups and professional societies, training workshops and support
of ancillary studies from academic and industry partners. Through this coordinated effort, CureGN is prepared
to accelerate improvements in the care of patients with glomerular disease.

Public health relevance
LAY NARRATIVE MCD, FSGS, MN, and IgAN are rare glomerular diseases of the kidney that cause serious illness including kidney failure and high mortality, generating enormous individual and societal burden. CureGN has assembled nephrologists, researchers with expertise in different scientific disciplines, and patients in a consortium that maintains and analyzes a large, longitudinal observational database and biosamples like blood, urine, and images of kidney biopsies. This initiative has developed a critical infrastructure that will advance our ability to study, classify, characterize, diagnose, and treat primary glomerular diseases of the kidney.